Control of CD8+ T cell Memory Homeostasis via Extracellular Damage Sensors ARTC2 & P2RX7

PROJECT SUMMARY/ABSTRACT
Many types of resident leukocytes live within the tissues of the body, acting as frontline defenders against
infection as well as fulfilling homeostatic tissue support roles. Tissue resident memory T cells (TRM) are poised
to respond to antigen-specific and non-specific signals at sites of tissue injury. Extracellular adenosine
triphosphate (ATP) and nicotinamide adenine dinucleotide (NAD+) are evolutionary conserved “danger signals”
released by cell damage. In mice and humans, extracellular ATP (eATP) is recognized by purinergic receptors.
Among those receptors, P2RX7 is a cell membrane channel preferentially expressed in immune cells that can
support T cell activation along with the development and maintenance of memory T cell subsets at physiologic
levels of eATP. However, P2RX7 activity is finely balanced: too little activity discourages memory cell
homeostasis whereas persistent, strong activation culminates in cell death via formation of a non-specific pore
structure. In mice, ARTC2.2 covalently modifies P2RX7 in response to extracellular NAD+ (eNAD+), amplifying
the sensitivity of P2RX7 eATP and encouraging its pro-apoptotic capacities. Previous work has suggested
ARTC2.2 and P2RX7 function to limit inappropriate T cell activation at sites of tissue injury, perhaps curtailing
development of harmful immune responses that would produce tissue damage in turn. However, autonomous,
cell-intrinsic effects of ARTC2.2 upon TRM are poorly defined. Utilizing a newly-generated, germline knockout
mouse strain deficient in ARTC2.2, this proposal aims to (1) characterize the cell-intrinsic contribution of
ARTC2.2 to CD8+ TRM homeostasis in primary immune responses and (2) assess ARTC2.2 effects upon TRM in
the setting of tissue injury incurred by sterile inflammation and secondary infection. Using murine models of
primary, secondary, and bystander immune responses, multi-parameter spectral flow cytometry and advanced,
high-resolution quantitative microscopy will identify and enumerate memory CD8+ T cell subsets from lymphoid
and non-lymphoid tissues. As release of eNAD+ and eATP can occur during processing of experimental tissue,
these studies purport to surmount technical challenges inherent to investigation of tissue-resident T cells.
Ultimately, these studies will help elucidate the role of ARTC2.2 in memory CD8+ T cell homeostasis and will
provide key insights on how “danger signals” and the sensing of cellular damage help build long-term immunity
against pathogens and limit deleterious immune activation following tissue injury.

Public health relevance
PUBLIC HEALTH RELEVANCE A significant proportion of the hematopoietic compartment is found not within the circulatory or lymphoid systems, but as resident cells in non-lymphoid tissues where they act as first responders against invading pathogens and to fulfill tissue-specific homeostatic roles in response to local inflammatory cues. Some of these evolutionarily conserved ‘danger signals’ are released by tissue injury and are suspected to modify the survival of resident T cells that represent a facet of the immunologic ‘memory’ that protects us from re-exposures such as previous infections and cancer recurrence. This proposal will address the ill-defined role of one such ‘danger signal’ sensor, ARTC2.2, and how it exerts control over tissue-resident CD8+ T cell development, maintenance, and function, with the potential to refine our models of protective immunity and its applications in vaccination and cancer immunotherapy.